Community-Based Organizations and Development of Implementation Strategies for Brain Injury Screening Resulting from Intimate Partner Violence

PROJECT SUMMARY/ABSTRACT
People who experience repeated brain injuries (BIs) before the brain recovers from the initial trauma are at a
high risk for neurological deficits, depression, suicide, and Alzheimer-like symptoms. Women who experience
intimate partner violence (IPV) are at high risk for injuries to their head, neck and face – potentially resulting in
an acquired BI. Among IPV survivors, BI can occur due to a traumatic brain injury (TBI) resulting from a bump,
blow, or jolt to the head or through strangulation. BI can have long term consequences on IPV survivors' well-
being and quality of life. Comprehensive screening among this vulnerable population and timely
neurorehabilitation interventions (i.e., referral to, and receipt of, evidence-based approaches to mitigate BI-
related health outcomes) have the potential to mitigate the impact of IPV-related BI and improve health
outcomes. Despite the high risk of BI among IPV survivors and the availability of evidence-based approaches
to address BI, there are no standard guidelines for BI screening in this group of women. The long-term goal is
to advance scientific understanding of implementation strategies related to the secondary prevention of IPV-
related BI that will inform future policies for timely screening, referral, and neurorehabilitation and ultimately
reduce neurological damage among this population. The objective of this project is to examine how screening
and detection of IPV-related BI can be effectively integrated into the workflow for community-based
organizations (CBOs) serving IPV survivors using a participatory approach. The central hypothesis has been
formulated based on preliminary studies and posits that CBO and stakeholder derived implementation
strategies can improve the adoption, implementation, and maintenance of timely screening/detection and
referral of IPV survivors at risk for a BI. Using the PRISM/RE-AIM framework and a participatory approach of
community-engaged dissemination and implementation, these aims will be pursued. Aim 1: To evaluate
adoption, implementation, and sustainability strategies of a brain injury screening intervention of IPV survivors
at CBOs with and without stakeholder developed implementation strategies. Aim 2. To determine the reach
and effectiveness of a brain injury screening intervention at CBOs serving survivors of IPV. Exploratory Aim.
Determine client and CBO implementer's perception of the screening intervention and implementation
strategies used in the project. The expected outcome is to increase currently limited knowledge of potential
implementation strategies to integrate routine screening and referral for IPV-related BI. This outcome is
expected to significantly contribute to the knowledge base needed to fully integrate the routine screening and
referral of IPV-related BI in CBOs serving IPV survivors. The project will also allow for the identification of
potential screening and referral strategies that can be used to connect patients with IPV-related BI to evidence-
based approaches to mitigate poor health outcomes and identify methods to achieve secondary prevention.

Public health relevance
PROJECT NARRATIVE Despite the high risk of brain injury among survivors of intimate partner violence, there are no standard guidelines for brain injury screening and referral in this group of women that can provide them with timely support and help mitigate the impact of brain injury. Using a participatory approach, we will examine how screening and referral of intimate partner violence-related brain injury can be effectively integrated into the workflow of community-based organizations serving intimate violence survivors. The public health impact will be an advanced scientific understanding of implementation strategies related to the secondary prevention of brain injury among community organizations serving survivors of intimate partner violence and this information will help inform future policies for timely screening, referral, and neurorehabilitation and ultimately reduce neurological damage in this population.